Frontiers in Cancer Research (SEPA Supplement)

PROJECT SUMMARY/ABSTRACT Educational Resources to Promote SARS-CoV-2 Vaccine Confidence Educational Resources to Promote SARS-CoV-2 Vaccine Confidence is a supplement to an existing Science Education Partnership Award, Frontiers in Cancer Research (“Frontiers”). The parent grant was awarded to the Science Education Partnership (SEP) at Fred Hutchinson Cancer Research Center (“Fred Hutch”). For this proposal, SEP has partnered with the COVID-19 Prevention Network (CoVPN) headquartered at Fred Hutch, and the Fred Hutch / UW Cancer Consortium’s Office of Community Outreach and Engagement (OCOE). The Frontiers parent program is designed to meet two goals of the National Institutes of Health (NIH) and National Institute of General Medical Sciences (NIGMS): to increase the STEM content knowledge and pedagogical skills of teachers and to engage students, especially those from underserved populations, in basic and clinical medical research. Overall, the Frontiers parent grant aims to increase public understanding of basic molecular and cellular biology, how this knowledge informs research questions, and how clinical research translates into cancer therapies and cures. Our program also explores the ethical implications of research-related topics. Another goal of the parent grant is to introduce students, particularly those from backgrounds underrepresented in the biomedical sciences, to career possibilities in research. This supplement builds on the existing aims of the parent grant as well as the stated needs of educators and community outreach specialists. 1) The supplement aims to inspire vaccine confidence in students and community members through high quality scientific animations, informational videos targeted to youth, and recorded scientific talks and tours. We will explain the science of vaccine development, address common misconceptions, build resources for Spanish-speaking communities, and expand our existing video offerings to include materials created by students targeted towards youth. Additionally, we will develop videos of vaccine research and testing being conducted through the CoVPN network for our Hutch@Home virtual outreach series. 2) We will also create lessons and educational materials that can be used with the resources we develop. Drawing on our extensive curriculum experience, we will develop lesson plans about vaccine science that utilize our new videos and animations and that can be used by secondary school science teachers. Additionally, we will develop scripts and templates to support community health educators and trainers use the newly developed resources.

Public health relevance
PROJECT NARRATIVE Frontiers in Cancer Research (“Frontiers”) addresses the needs identified by the NIH for resources that help teachers grow both in their STEM learning and as professionals, and for strategies to help engage youth from underserved populations in biomedical research. Frontiers provides curriculum, hands-on scientific resources, and research experiences for secondary school teachers to develop the expertise needed to teach what cancer is, how it can be treated, and what kind of careers are possible in biomedical research. Frontiers also helps students understand how biomedical advances are making novel approaches to cancer research and treatment possible, provides them with an opportunity to explore social and ethical questions surrounding biomedical research, and fosters a broader understanding of the role and importance of science in their lives.